Improved protein-based meningococcal serogroup B vaccines

Project Summary/Abstract
Two protein-based vaccines are licensed in the U.S. for prevention of meningococcal group B (MenB)
disease in adolescents and young adults. One vaccine contains two Factor H binding protein (FHbp)
Ags, one from each of the two phylogenic sub-families; the other contains one FHbp sub-family B Ag
and three other potentially protective Ags. The former vaccine has limitations in protection against
strains with no or low FHbp expression (10-20% of strains) and the latter has limitations against the
~40% of strains with FHbp in sub-family A and lacking another matched Ag. Our previous studies in
human complement Factor H (FH) transgenic mice and infant rhesus macaques showed that binding
of FH to FHbp decreases the magnitude of the protective Ab responses. Further, our colleagues have
shown that human FH decreases the protective Ab responses to an alternative FH ligand known as
Neisserial surface protein A (NspA), which is present in virtually all MenB strains. Since recruitment
of the complement down-regulator FH to the bacterial surface contributes to immune evasion, a
vaccine that targets both of these FH ligands would elicit Abs that effectively defeat this virulence
mechanism. In Aim 1, we will incorporate FHbp amino acid substitutions to decrease binding of FH
into optimally cross-protective FHbp sequence variants in each sub-family. In Aim 2, we will introduce
substitutions to decrease binding of human FH to NspA based on the known crystal structure of NspA
and to increase solubility of the recombinant protein using random mutagenesis and a fluorescent
reporter system. For both Aims 1 and 2, we will test the optimized antigens for FH and MAb binding
in vitro, evaluate immunogenicity in wild-type and human FH transgenic mice and test the serum Ab
protective activity. In Aim 3, we will develop a combination FHbp-NspA vaccine that will combine an
engineered FHbp sequence variant from each sub-family and an engineered NspA Ag. We will test
the combination vaccine compared to a licensed MenB vaccine, first in human FH transgenic mice
then in infant rhesus macaques with high binding of FH to wild-type FHbp and NspA. For each of
these studies, we will determine the magnitudes of the bactericidal Ab responses against MenB
strains that are specific for each of the two Ags (i.e. lacking or with very low expression of one of the
two Ags). We also will test passive Ab protection in human FH transgenic infant rats. The data will
support development of a second-generation MenB vaccine that elicits higher and more sustained
protective Ab responses and broader protection than the currently licensed vaccines. Since binding of
complement regulators is a common microbial virulence mechanism, the results also will have broad
implications for the development of vaccines against other microbes that bind complement regulators
or other host molecules.

Public health relevance
Project Narrative/Relevance The two meningococcal group B (MenB) vaccines for prevention of sepsis and meningitis do not have a universal recommendation for adolescents and young adults, and are not licensed for use in infants or young children, who are at the highest risk of MenB disease. The goals of this project are to engineer improved Factor H binding protein (FHbp) and Neisserial surface protein A (NspA) antigens and to test a combination protein-based vaccine in non-human primates. By targeting two alternative meningococcal ligands for complement Factor H, our studies have the potential to increase the breadth and duration of antibody protection elicited by next-generation MenB vaccines.